Inhibition of hepatic (V)LDL production by a novel antagonist of carboxyl esterase 1

Project Summary
We used a human iPSC-derived hepatocyte platform to identify a family of structurally related
small molecules that can reduce the production of APOB by the liver. These small molecules
are highly effective, do not cause abnormal lipid accumulation, and have a chemical structure
that is distinct from any known cholesterol lowering drug. Such compounds have the potential to
treat hypercholesterolemia and steatosis. In the current application we propose to define the
molecular mechanisms through which the compounds act. In preliminary data we show that the
compounds inhibit human carboxylesterase 1 (CES1). In the three proposed aims we will i)
identify the binding characteristics of the compounds to CES1 and define their specificity using
crystallography and biochemical assays, ii) use iPSC-hepatocytes to definitively establish the
role of CES1 in mediating (V)LDL-cholesterol production by the compounds, and iii) determine
the efficacy of the compounds in lowering cholesterol and steatosis humanized mouse models.

Public health relevance
NARRATIVE We have identified a series of novel compounds that reduce the production of Low Density Lipoprotein Cholesterol (LDL-C) from the liver, and we reason that the compounds act as irreversible inhibitors of carboxylesterase 1 in hepatocytes. They represent a new class of compounds that could potentially be used to treat homozygous familial hypercholesterolemia (hoFH), steatosis, and as a complement to statins to help the general population meet cholesterol goals. We propose to determine the compound’s mechanism of action and whether they are effective in humanized mouse models.